ATUSA: World's First Wearable and Automated 3D Breast Ultrasound System with AI

Breast cancer (BC) is a universal health challenge, affecting millions of women worldwide annually. This
malignancy is a leading cause of death among women, underscoring its profound significance. Detecting BC at
an early stage not only improves treatment outcomes but also significantly enhances survival rates. Currently,
mammography is the standard of care for diagnosis of BC, and it is recommended that screening procedures
commence at the age of 40, particularly due to the rising incidence of BC in women who are under the age of
50. Although mammography decreases BC-associated mortality, there exist distinct challenges with
mammography alone for general population screening. For example, there is often inadequate healthcare
accessibility for certain populations living in low-resource areas or rural setting which results in heightened BC mortality. In addition, fear of painful mammogram experience also contributes to the lack of timely BC diagnosis in some women. Screening mammography also exhibits inherent sensitivity limitations and often misses BC at earlier stages, especially for women with dense breasts, who comprise approximately 47% of women in the U.S. It is thus recommended that women with dense breasts upon mammographic exam undergo supplemental screening procedures such as ultrasound or MRI. Unfortunately, these imaging procedures are expensive and/or dependent upon the availability of specially trained breast sonographers and are not widely available to general populations. There is thus an urgent need for the development of innovative screening methods that facilitate BC detection in nascent stages and that are also deployable to the primary care setting and can be operated independent of user experience level. To address these problems, iSono Health has
developed the ATUSA imaging platform, which represents a major advancement in supplemental BC screening. This novel system consists of an adjustable wearable imaging device that can rapidly perform whole breast scans in ~2 minutes coupled with artificial intelligence (AI)-assisted algorithms that accurately identify and diagnose BC at an early stage. The goal of this Direct-to-Phase II proposal is to develop and validate Lesion Classification, Lesion Segmentation, and Density Calculator AI models for 3D ATUSA images. Successful outcomes of this project will establish baseline measures of the ATUSA diagnostic performance. Validation results will allow iSono Health to submit a second FDA clearance of AI indications and commercially launch ATUSA. The ATUSA platform will transform how women access supplemental breast imaging and increase the number of women receiving adequate breast imaging and timely diagnosis, thus saving lives.

Public health relevance
Breast cancer (BC) accounts for approximately 30% of all new female cancer diagnoses in the United States. Early disease detection is paramount for better prognosis and increased survival rates, but conventional mammogram suffers from poor sensitivity in women with dense breasts, as well as inaccessibility in low resource settings. To address these issues, iSono Health has developed the ATUSA imaging and AI-assisted diagnostic platform, which is a scalable, efficient, and cost-effective supplemental BC screening method that can be deployed in the primary care setting.